Evolution of glycan-reactive broadly neutralizing anti-v2 antibodies in HIV infec

DESCRIPTION (provided by applicant): The envelope glycoprotein of transmitted HIV is less glycosylated compared to viruses from later in infection. Glycans are added or shifted to escape strain-specific neutralizing antibodies, and in some cases these contribute to the formation of broadly neutralizing antibody epitopes. Thus, in some individuals, viral evolution may provide the stimulus for the development of broadly neutralizing antibodies. We hypothesize that early strain-specific neutralizing antibodies target exposed peptidic structures while later affinity matured antibodies from the same clonotype recognize the glycosylated epitope. A secondary hypothesis is that the inability of antibodies elicited in the RV144 vaccine trial to mediate neutralization is because they fail to recognize glycans. We will explore these hypotheses using well-characterized serial samples from HIV-infected women in the CAPRISA cohort and from the RV144 HIV vaccine trial. Serum samples will be run on glycan arrays to determine whether glycan-binding antibodies are preferentially found in infected women who later develop neutralization breadth and to assess overall levels of glycan reactivity in RV144 samples. The finding that V2 binding antibodies that recognize the K169 residue in the V2 region are an immune correlate in RV144, has led us to focus on infected women who develop broadly neutralizing antibodies that target this same residue and are glycan-dependent. We will use novel V1/V2 scaffolds that bind the glycan-reactive broadly neutralizing PG9 monoclonal antibody to study how V2 antibodies develop. Scaffolds will be modified in order to characterize antibody specificities and glycan-reactivity over time, and used in adsorption experiments to assess the neutralizing capacity of V2-directed plasma antibodies. We will define whether anti-V2 binding antibodies are qualitatively different in individuals who later develop broadly neutralizing anti-V2 responses, and whether the V2 specificities elicited in RV144 are similar to those elicited in natural infection. Finally, we will assess whether V2 binding antibodies are the precursors of broadly neutralizing V2 antibodies that develop in some HIV infected individuals by isolating V2 antigen-specific mAbs using single B cell sorting at early and late time points from selected CAPRISA women. These mAbs will be assessed for glycan-binding and functional activity including neutralization and inhibition of α4β7 binding. Antibody genes from these and other broadly neutralizing mAbs, recently isolated through B cell culture by our collaborators, will be analyzed to determine which features associate with the acquisition of neutralization breadth. Collectively, these data will reveal the pathway to neutralization breadth for anti-V2 antibodies, which may have important implications for understanding and improving on the RV144 results.

Public health relevance
PUBLIC HEALTH RELEVANCE: Vaccines generally work by inducing protective antibodies. Antibodies found in some HIV-infected people are able to prevent the virus from entering cells by binding to the sugars that surround the HIV particle. We aim to analyze how antibodies that bind to sugars develop in HIV-infected and vaccinated people. This information will be critical for understanding how to design a more effective HIV vaccine. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The HIV envelope is heavily coated with predominantly high mannose glycans which are relatively conserved. These provide structural integrity as well as protection from antiviral antibodies. Increasingly, glycans have been shown to be the targets of broadly cross-neutralizing (BCN) antibodies which develop in some HIV- infected individuals. Our recent data suggest that viral evolution, particularly the shifting or addition of glycans plays an important role in creating the antigenic stimulus for BCN antibodies. Using glycans arrays, we aim to explore whether antibodies able to bind glycans are induced by HIV infection and are more commonly found in individuals who later develop BCN antibodies. We propose to focus on antibodies that target the V2 region, shown to correlate with protection against HIV-1 infection in the RV144 trial, to explore glycan-binding in HIV infection and vaccination. Finally we plan to isolate HIV-specific monoclonal antibodies (mAbs) from acute and chronic infections to test the notion that early antibodies recognize protein epitopes while later antibodies target glycans on the same epitope. We speculate that binding to critical glycan moieties is needed for the development of neutralization breadth. Our overall hypothesis is that early in infection, autologous neutralizing antibodies recognize exposed protein structures, while later affinity matured BCN antibodies from the same clonotype bind the glycosylated epitope. This work will be done using the CAPRISA 002 acute HIV infection cohort based in South Africa, one of the regions of the world most in need of an HIV vaccine. The value of this African cohort comes from the availability of stored samples from HIV-1 subtype C infected individuals where the neutralizing antibody specificities from acute infection through to the development of breadth are well characterized. We will make use of the latest technologies, including custom- designed glycan arrays, scaffolded V2 proteins that present more conformationally-intact structures as well as antigen-specific memory B cell sorting and single cell immunoglobulin gene PCR, to isolate relevant antibodies to fulfil the following three specific aims: Specific Aim 1: To assess glycan-binding antibodies in HIV infection and vaccination. Among the women in the CAPRISA 002 cohort who develop neutralization breadth, almost all have antibodies that target glycosylated epitopes. Thus, we hypothesize that glycan binding antibodies will be enriched in individuals who develop neutralization breadth. This will be explored in collaboration with Dr Jeff Gildersleeve, a glycobiologist at the National Cancer Institute, by analyzing glycan array binding patterns and kinetics using serum samples from women who do or who do not develop BCN antibodies. A secondary aim is to examine glycan-binding among participants in the RV144 trial, with the notion that no or limited glycan- binding is responsible for their lack of neutralizing activity. Specific Aim 2: To characterize anti-V2 antibody responses in HIV infected and vaccinated individuals. The recent finding that anti-V2 binding antibodies correlated with protection from HIV infection in the RV144 trial has raised significant interest in the evolution and function of V2-directed antibodies. Some CAPRISA participants develop glycan-dependent BCN antibodies that target the same residues in the V2 loop that were identified in the RV144 sieve analysis as being under selection pressure. We speculate that anti-V2 binding antibodies in individuals who later develop broadly neutralizing anti-V2 responses will be qualitatively different to those that do not. For this we will use scaffolded V1/V2 proteins to assess the specificity, functional capacity and glycan-dependence of V2 antibodies elicited by infection and vaccination. This will allow us to determine if vaccine-elicited V2-directed antibodies share any features with anti-V2 antibodies elicited in natural infection that are on the path to neutralization breadth. Specific Aim 3: To isolate anti-V2 mAbs from individuals with and without plasma neutralization breadth. The use of mAbs is the most powerful and direct means of studying antibody properties. We propose to make use of the V1/V2 scaffolds, which efficiently deplete V2 antibodies in infected plasma, to isolate mAbs from 2 individuals (CAP256 and CAP257) who develop broadly neutralizing anti-V2 antibodies that target glycans. Their heavy and light chain genes will be compared to BCN mAbs that have or will be isolated from these women later in infection. We will explore whether V2 binding antibodies are the precursors of broadly neutralizing antibodies that develop in these HIV infected individuals. Furthermore, mAbs will be isolated from 2 additional women who develop high titre anti-V2 binding antibodies but who do not develop breadth. All these antibodies will be functionally and genetically characterized to determine if glycan-binding evolves together with the acquisition of functional activity including neutralization breadth, ADCC and α4β7 binding.